Mechanisms of acentrosomal spindle assembly and stability during oocyte meiosis

Project Summary
Organisms that reproduce sexually utilize a specialized cell division program called meiosis to reduce their
chromosome number by half to generate haploid gametes. Proper execution of this process is crucial for a
successful pregnancy, since errors in meiotic chromosome segregation result in aneuploidy (incorrect
chromosome number in the embryos), the leading known cause of miscarriages and birth defects in humans.
Meiosis in females is especially error prone and this vulnerability has a profound impact on human health: it is
estimated that 10-25% of human embryos are chromosomally abnormal, and the vast majority of these defects
arise from problems with the female meiotic cells (called oocytes). However, despite the importance of female
meiosis for successful reproduction and human health, surprisingly little is known about the mechanisms that act
to ensure accurate chromosome partitioning in oocytes.
Oocytes have some special features that necessitate the use of novel cell division mechanisms. Perhaps
most significantly, oocytes lack centrosomes, which define and organize the spindle poles in other cell types;
therefore, spindles in these cells must assemble using different mechanisms. Using C. elegans as a model, we
previously demonstrated that acentrosomal spindle assembly proceeds by 1) nucleation/stabilization of
microtubules adjacent to the disassembling nuclear envelope, 2) sorting of microtubules such that their minus
ends are positioned at the periphery of the array, 3) organization of these ends into nascent poles, and 4)
coalescence of these sites until bipolarity is achieved. Moreover, we have identified proteins required for key
events in this pathway, shedding light on the molecular mechanisms underlying this form of spindle assembly.
Building on these discoveries, the goals of the proposed work are to: 1) deepen our understanding of
acentrosomal spindle assembly and organization, and 2) investigate mechanisms that promote the formation
and stability of acentrosomal spindle poles in both C. elegans and mammalian oocytes. These approaches will
enable us to gain a mechanistic understanding of oocyte meiosis, an important yet poorly understood form of
specialized cell division.

Public health relevance
Project Narrative It is estimated that 10-25% of human embryos have the wrong number of chromosomes, resulting in a high incidence of miscarriages and birth defects. Most of these abnormalities are the result of mistakes generated when female reproductive cells (oocytes) divide, yet surprisingly little is known about the mechanisms that underlie the vulnerability of oocytes to these errors. This project seeks to gain insight into this important question, focusing on the assembly and stabilization of a structure called the spindle that mediates the segregation of chromosomes during cell division.